Phage-based therapeutic gene delivery targeting multiple compartments in solid tumors

ABSTRACT
Triple-negative breast cancer (TNBC) is an aggressive subtype of breast cancer that accounts for approximately
10-20% of all breast carcinomas and is often associated with poor prognosis. While conventional therapies such
as chemotherapy, radiotherapy, and immunotherapies help the management of TNBC, most patients still
develop distant metastasis and have a low overall survival rate. To date, there are only a few specific treatment
options approved for this tumor subgroup, and the development of novel targeted therapies is an unmet need.
Importantly, TNBC often presents as advanced disease, and these tumors are also often bereft of recognized
molecular targets that can be found in other subtypes, limiting their therapeutic options. However, tumor-
associated macrophage (TAM) infiltration in TNBC is frequently observed, and the complex interplay between
immune cells and tumor cells within the tumor microenvironment (TME) can lead to disease progression.
Specifically, signals generated in the TME can cause immunosuppression, promoting angiogenesis and immune
evasion, which leads to tumor development. The interplay of M1 and M2 macrophage populations that coincide
with these tumor markers are particularly important in the TME. Moreover, a high density of TAMs, particularly
M2 macrophages, is associated with poorer outcomes in various cancers, including TNBC. This provides a
strong basis for exploiting TAMs as potential therapeutic targets. Specifically, novel efforts to increase M2 to M1
repolarization are promising therapeutic approaches in TNBC. Here we propose a two-pronged approach to
target the M2-rich TAM population, reversing immune subversion, combined with the targeted destruction of the
tumor cell population, using a gene delivery approach. Prokaryotic viruses such as bacteriophage have no
tropism for mammalian cells, but can be engineered to deliver genes with low efficiency. On the other hand,
animal viruses have potential for targeted gene therapy but require elimination of native tropism for mammalian
cells, so we combined the favorable biological attributes of eukaryotic and prokaryotic viruses to facilitate
targeted systemic gene therapy applications. In Aim 1, we will explore the unique attributes of AAVP, a targeted
hybrid vector containing cis-genomic elements from adeno-associated virus (AAV) and phage (P) displaying
ligand motifs to target multiple compartments of TNBC—tumor cell and associated vasculature with RGD4C and
TAM with CSSTRESAC—and deliver human tumor necrosis factor (TNF) to modulate the tumor
microenvironment in a syngeneic model of TNBC. Aim 2 is dedicated to the characterization of the
immunomodulatory effects of TNF expression within the tumor microenvironment and the potential repolarization
of anti-inflammatory M2-like TAMs to a pro-inflammatory M1-like TAM population.

Public health relevance
NARRATIVE Targeted gene therapy approaches are reemerging as attractive experimental clinical agents; our ligand-directed hybrid virus of adeno-associated virus and bacteriophage (AAVP) is a targeted gene delivery vector that has been used in several formulations displaying targeting ligand peptides to deliver clinically applicable transgenes. Here we will evaluate a novel combination of two AAVP constructs to target multiple compartments and deliver tumor necrosis factor (TNF) in a clinically relevant model of breast cancer. The double-cyclic RGD4C motif ligand is specific for alpha v integrins expressed in tumor cells and associated vasculature, and the recently reported CSSTRESAC peptide ligand is specific for protein disulfide-isomerase A3 (PDIA3), a novel marker on the surface of tumor associated macrophages, and displays immunoregulatory activity.